Lymphatic-adipocyte interactions in obesity and lymphedema

Project Summary/Abstract
Adipose tissue homeostasis and expansion requires the coordination of multiple cell types to accommodate
increases in tissue volume and metabolic requirements. An important component of adipose tissue regulation is
the lymphatic vascular system, which is responsible for the removal of extracellular fluid and for immune cell
trafficking from the tissue to lymph nodes. In obesity, the relationship between fat and lymphatics becomes
dysregulated, resulting in lymphatic vessel dysfunction, including decreased vessel formation, increased
permeability, and diminished contractility. Conversely, in conditions of impaired lymphatic function, such as after
lymph node resection, adipose tissue is dysregulated and experiences accelerated expansion in the affected
area.
Given the increasing prevalence of obesity and its complications, as well as the burden of lymphedema in millions
of post-surgical patients, the mechanisms which regulate the relationship between adipose tissue and lymphatics
are of significant interest. Broadly, this proposal will investigate cell-type specific interactions which govern this
relationship. The lab’s single-nucleus RNA sequencing data revealed that lymphatic endothelial cells express
the leptin receptor, indicating a role for leptin—an adipocyte-produced hormone which regulates organismal
energy balance—in lymphatic function. Preliminary studies have demonstrated that leptin augments lymphatic
tube formation and impacts gene expression, and Aim 1 of this proposal describes a plan to further define leptin’s
role in lymphatic function. Aim 2 proposes to study the adipocyte-lymphatic relationship from an alternative
direction by performing single-nucleus RNA sequencing on adipose tissue associated with lymphedema in
human subjects, thereby revealing changes in cellular composition and transcriptional profiles after disruption of
local lymphatics.
This five-year career development program will build on and expand the candidate’s skills and experience in
studying adipocyte biology, animal models of metabolic dysfunction, and single-cell RNA sequencing, while also
employing a number of new techniques to evaluate lymphatic vessel function. By assembling a mentorship team
and collaborators who are well-equipped to facilitate these studies, in addition to supplementary didactic work,
this project will enable the candidate’s transition to an independent career as a physician-scientist in the fields
of adipose tissue biology and metabolism.

Public health relevance
Project Narrative The relationship between adipose tissue and its resident lymphatic vasculature is complex and bidirectional. While defective lymphatic function, as seen in lymphedema, promotes fat deposition, obesity, conversely, compromises lymphatic flow. By exploring lymphatic endothelial cell communication with other adipose tissue cell types, this proposal aims to improve our understanding of how the lymphatic system contributes to adipocyte biology and overall metabolic health.